Core D: External Network Core

Core D. External Innovative Network Core
PROJECT SUMMARY/ABSTRACT
Advancing our current understanding and research in population health and the demographic, social, and
economic dimensions of aging requires an interdisciplinary and collaborative approach. We will continue to
develop meaningful work between researchers and institutions through the External Collaborative Network
(ECN). Formerly Core C (in the current cycle), the ECN has developed over the past three years as the
Population Ecology, Aging, and Health Network (PEcAHN), bringing together researchers from regional and
U.S. institutions with life course- and community-focused projects at field sites around the U.S. and around the
world. The overarching focus of PEcAHN is to address persistent health disparities faced by low-income, rural,
and minority communities. By building a network PEcAHN features annual meetings for researchers across
sites to gather and share discoveries, learn new and promising methods from their peers, and to develop
collaborative projects across sites. By fostering the sharing of ideas and methods across sites, and through
formal analyses in papers and other multi-site collaborations, PEcAHN supports the P30 aim of advancing
research in population aging and addressing health disparities. The network also promotes early career
researchers, another P30 aim, by supporting their involvement in these meetings and providing opportunities to
lead collaborative projects and papers.

Public health relevance
Core D. External Innovative Network Core NARRATIVE Core D of this project will support an collaborative network of researchers engaged in long-term, communitybased, life-course focused research in rural and remote communities in the U.S. and abroad. This group, the Population Ecology, Aging, and Health Network (PEcAHN) is already active and includes more than 20 researchers from 13 projects worldwide. Aims of Core D are to 1) develop and expand PEcAHN to include more researchers and sites, 2) support annual meetings and collaborative research focused on rural health, and 3) support and develop early career researchers in this area.